Molecular Engineering of Natural Light-Gated Chloride Channels for Optogenetic Inhibition

PROJECT SUMMARY/ABSTRACT
Targeted modulation of neural activity is an essential approach in basic and clinical neuroscience research.
Optogenetic proteins, such as light-activated ion channels or pumps, enable optical control of neuronal activity
with exquisite spatiotemporal precision. Thus, they provide powerful means to interrogate how neural activity
contributes to brain functions and alter pathological activity to treat neurological disorders. A variety of
excitatory optogenetic tools have been developed to meet different needs of activation paradigms. In contrast,
inhibitory tools remain underdeveloped. The most well-developed light-driven ion pumps are still not sufficiently
effective in silencing neurons due to their intrinsically low photoefficiency and pumping activity. Newly
developed light-gated potassium channels also suffer from their small photocurrents and slow current kinetics.
Our discovery of natural light-gated chloride channels, Guillardia theta anion channelrhodopsins 1 and 2
(GtACR1 and GtACR2), led to a new class of inhibitory optogenetic tools that are highly sensitive to light, have
outstanding anion selectivity, exhibit time constants of milliseconds, and can generate 10–100-fold larger
photocurrents in mammalian cells than previous tools. However, we and others discovered that light activation
of light-gated chloride channels in mouse neurons depolarizes the axon and presynaptic terminals to trigger
neurotransmitter release even though it inhibits action potentials at the soma. This excitatory action is due to
the endogenous high concentrations of chloride in the axon and presynaptic terminals, which create a
depolarizing chloride efflux upon channel opening. Thus, axonal excitation impedes the goal of neuronal
silencing and complicates the interpretation of experiments using light-gated chloride channels. Another
important limitation is that the action spectra of light-gated chloride channels are all within the blue to green-
light ranges, limiting their effectiveness in deep brain tissues and flexibility in multiplex optogenetic
applications. Therefore, the objective of this project is to overcome these two major limitations of light-gated
chloride channels. We will harness protein trafficking machinery, structure-based molecular engineering, high-
throughput screening, and protein evolution in nature to eliminate the excitatory effect and expand the action
spectra range of natural ACRs. We propose to exploit endogenous protein trafficking mechanisms to restrict
ACRs within neuronal somatodendritic domain (Aim 1), perform structure-guided high-throughput mutagenesis
screens to create ACR variants with robust outward rectification and photocurrents (Aim 2), and identify
spectrally shifted ACR variants through natural ACR homolog screens and high-throughput mutagenesis
screens (Aim 3). The proposed research capitalizes on a powerful synergistic collaboration of biophysics,
protein engineering, high-throughput screening, neuronal physiology, and system neuroscience. The
successful completion of this project will present to the neuroscience community a set of much improved
inhibitory optogenetic tools with potent efficacy, minimal side effects, and diverse spectral sensitivities.

Public health relevance
PROJECT NARRATIVE Perturbation of neuronal activity impairs brain functions, thereby contributing to the pathogeneses of many neurological disorders such as epilepsy, Parkinson’s disease, and autism. The proposed research will develop novel molecular tools for optical control of neuronal activity, which will facilitate the investigation and potentially improve the treatment of pathological activity underlying neurological disorders.